Boston OAIC: A Translational Approach to Function Promoting Therapies

Summary
The overall objective of this administrative supplement is to support a developmental project linked to the
Translational Discovery Core of the Boston Older Americans Independence Center. The primary aim of
the project is to optimize liquid chromatography tandem mass spectrometry (LC-MS/MS) assays for the
measurement of biologically active mature forms of GDF11, myostatin, oxytocin, and acyl ghrelin that do not
have any interference from respective proproteins or related peptides, and that are calibrated against well-
characterized standards generated by the CDC's Hormone Standardization Program. The CDC laboratory will
generate high quality reference materials to establish the traceability of procedure to a value that represents
the best estimate of the true value. The generation of a commutable reference material by the CDC Laboratory
will ensure accuracy, and help reduce inter-assay and inter-laboratory variability.
Upon successful completion of this developmental project, these harmonized assays will be made available to
the investigators within the Boston OAIC and other OAICs, as well as to the scientific community at large
through the Translational Discovery Core of the Boston OAIC. These assays will be of substantial value to NIA-
funded investigators within Boston OAIC (Bhasin, Wagers, Lee), other OAICs (Lee at University of Connecticut
OAIC, Farmington, CT; investigators associated with the CARGO Project) and investigators outside the Pepper
Center Network (Lawson at Mass General Hospital; Orwoll at the University of Oregon, Cawthon at UCSF).
The availability of accurate and sensitive assays would be a useful resource to many researchers and would
extend the range and quality of this NIH-funded research. The project represents a historical opportunity and
an important step towards harmonization of optimized assays for the measurement of geronic factors and their
related proteins and peptides.

Public health relevance
The parent grant supports The Boston Older Americans Independence Center (Boston OAIC), a P30 Center that represents an interdisciplinary research network among aging researchers from Boston's leading academic centers to foster translational research in function promoting therapies (FPTs) – interventions that reduce the burden of disabling functional limitations. The objective of this administrative supplement is to support a developmental project linked jointly to the Translational Discovery Core of the Boston OAIC. This supplement aims to develop optimized LC-MS/MS assays for the measurement of biologically active forms of growth and differentiation factor-11, myostatin, oxytocin, and acyl ghrelin with the assistance of the Hormone Standardization Program of the Centers for Disease Control and Prevention, which will be made available to the investigators within the Boston OAIC and other OAICs, as well as to the scientific community at large through the Translational Discovery Core of the Boston OAIC.